Conserved NO-Binding Cytochromes in Burkholderia pseudomallei and Other Pathogens

SUMMARY
Burkholderia pseudomallei is a recognized bioterrorism agent by the Centers for Disease Control and
the causative agent of melioidosis – an emerging disease in the United States and in other developed
countries. Upon infection, B. pseudomallei persists despite rapid host immune responses including
exposure to macrophage-derived nitric oxide (NO). Currently, the mechanism employed by B.
pseudomallei and other pathogens to evade host-produced NO is unknow. We've identified through
bioinformatic studies a widely conserved gene in B. pseudomallei and in numerous other bacterial
pathogens that encodes for a unique mono-heme cytochrome. We've tentatively designated this protein
cyt BP1. Proteins in this family react with N-oxides including NO; however, no member in pathogens
have been characterized. We hypothesize that cyt BP1 and its homologues which are present in a large
group of persistent pathogens are key defense proteins that detoxify host-produced NO. We therefore
propose to characterize cyt Bp1 and eventually its orthologues in other pathogens. Findings from this
proposed study could be key in elucidating the mechanism employed by persistent pathogens in NO
defense, persistence, and virulence. Specifically, we aim to 1. characterize the phenotype of disruption
mutants encoding for bp1orthologues in model organisms 2. characterize the catalytic function of cyt
BP1 in NO conversion; and 3. determine the structure-function relationship of cyt BP1. This proposal will
support the very first characterization of what is likely a NO-detoxifying protein from B. pseudomallei and
other pathogens. Elucidation of cyt BP1 function could be a key first step in the mechanistic
understanding of the NO-defense system, and in the development of therapeutic agents for the
treatment of persistent infections.

Public health relevance
NARRATIVE Burkholderia pseudomallei is a recognized bioterrorism agent by the CDC that persists upon infection despite host immune responses, including exposure to the radical cytotoxic gas nitric oxide (NO). This persistence leads to melioidosis, an emerging disease in the US which has a high mortality rate. Determining the mechanism of NO avoidance by B. pseudomallei, and in other NO-evading persistent pathogens, could lead to the development of new therapeutic agents for melioidosis and other persistent diseases.